SUPPORT FOR THE FEDERAL INTERAGENCY FORUM ON CHILD HEALTH AND FAMILY STATISTICS

This is an Inter-Agency Agreement between the National Center for Health Statistics (NCHS) of Center for Disease Control and Prevention (CDC) and NICHD.
This agreement is to provide funds to support the work of the Federal Interagency Forum on Child and Family Statistics (Forum) and the production of the America’s Children report and related publications. The purpose of the Forum is to foster collaboration among Federal agencies that produce or use statistical data on children and families. Specifically, the Forum seeks to improve both the quality and use of data on children and families by investigating questions of data quality, data measurement, and data integration, and identifying information gaps and data inconsistencies. The purpose of the Forum report, America’s Children: Key National Indicators of Well-Being, is to provide a summary of national indicators of children and families’ well-being in an easy to use, non-technical format. Through this publication and other means, the Forum coordinates the development and use of statistical databases among Federal agencies, promotes communication among data producers, researchers, and public policymakers, and addresses concerns regarding collection, access, and dissemination of data.